P30 Administrative Supplement to Cancer Center Support Grant to Strengthen NCI-Supported Community Outreach Capacity through Community Health Educators of the National Outreach Network.

Abstract: Please see the Research plan, as the FOA specified to put the abstract in this section.

Public health relevance
Project Narrative: Among the fifty states, New Hampshire ranks number one in the incidence of breast, esophageal, and urinary bladder cancers, the latter reflecting the association between bladder cancer and environmental arsenic exposure linked to frequent use of rural well water within the “Granite State”. Of similar concern, Vermont ranks number one in the incidence of uterine cancer and second in the incidence of melanoma. Norris Cotton Cancer Center continues to create important new knowledge, engage our community, and influence public policy related to these and other cancers in a manner directly relevant to these unique catchment area public health needs.